Measuring Gender in the Healthy Oregon Project

PROJECT SUMMARY
The sexual and gender minority (SGM) community (i.e., LGBTQ+) is vastly underrepresented in cancer
research. As such, there are limited data on cancer-related health outcomes and inequities, and a lack of
evidence-based approaches to improve health equity. Importantly, the SGM umbrella term encompasses a
heterogenous population, but much work to date has either combined subgroups or failed to disaggregate
transgender and gender diverse (TGD) individuals. As such, there is an even greater need to include TGD
individuals in research, and to include meaningful and accurate assessment of gender identity in that research.
The NIH has developed recommendations for improvements in clinical research to improve SGM health. These
include improved and expanded collection of gender identity and sexual orientation data, attention to
intersectionality, and community engagement to ensure cultural competence/humility. The proposed
administrative supplement project follows these recommendations by engaging TGD participants in the
process of creating gender measurement items, testing the new measures in a large existing cohort, and
conducting descriptive analyses to inform future research. The primary aim of this project is to conduct a
mixed-methods study to guide decisions about terminology used for assessing gender within the Healthy
Oregon Project (HOP). Much progress has been made toward improvement in and implementation of gender
measurement, but persistent challenges remain. More specifically, current recommendations for
language/terminology and response options used may not adequately and inclusively capture gender or the
fluidity of gender identity. Such issues can lead to systemic gender miscategorization and low response rates
in research, as well as contribute to discomfort and feelings of exclusion among TGD individuals. With the goal
of improved and inclusive gender measurement, we propose to identify and test assessment items through an
iterative process of individual interviews, focus groups, survey implementation in a large community cohort,
and consultation with community stakeholders regarding results and recommendations. This work will add
novel data to the extensive data already collected through HOP on health behaviors and cancer screening. In
addition, the proposed supplement will facilitate improved data collection across the parent study cohorts that
are recruited through HOP and provide a valuable opportunity to address important future questions regarding
possible differences in follow on screening and prevention behaviors among TGD individuals who carry an
HBOC or Lynch mutation. More broadly, the results will contribute to the expanded collection of valid gender
identity data, the inclusion of TGD-specific data in research, and the improved assessment of cancer outcomes
and health disparities for TGD communities.

Public health relevance
PROJECT NARRATIVE This research will add novel data about gender identity to an ongoing large population-based study, and measures developed can be implemented and evaluated in other settings in future studies. Continued expansion and improvement of gender identity data collection across multiple contexts and populations is critical for monitoring disparities. This work is essential for identifying strategies to improve equity in cancer care and cancer outcomes.